Nanoparticle-encapsulated Epigenetic Inhibitors for Treatment of Inflammatory Bowel Diseases

PROJECT SUMMARY/ABSTRACT
Ulcerative Colitis (UC) and Crohn’s disease (CD), the two major types of inflammatory bowel disease (IBD), are
chronic diseases with recurrent symptoms and significant morbidity. There exists a lack of efficient medications
for IBD, primarily due to either limited efficacy or side effects. Therefore, there is an unmet medical need to
develop new effective treatments for IBD. Our compelling data using murine IBD models and human IBD patient
samples demonstrated that activation of bromodomain-containing protein 4 (BRD4), an epigenetic regulator, is
critical to the initiation of colonic inflammation in IBD. BRD4 inhibition reduces the inflammatory response but
does not affect the anti-apoptotic response, making this strategy much safer and better tolerated (Preliminary
data). Inhibition of BRD4 activation is an attractive target for the development of superior therapeutics for IBD,
especially for anti-TNFα-resistant patients. We have demonstrated that BRD4 inhibition blocks the pathological
activation of the BRD4 signaling, leading to the suppression of colonic inflammation in several murine models of
IBD and human samples of IBD patients. Our overall objective is to develop BRD4 inhibitor-loaded nanoparticles
for targeted therapy to areas of active colonic inflammation. For this purpose, we used several approaches to
guide the design of colon mucosal inflammation-targeted nanoparticles. In our pilot studies, we have successfully
encapsulated our new generation BRD4 inhibitors ZL0513, ZL0591, and ZL0742 into biodegradable
nanoparticles using FDA-approved polymers. No apparent cell death was detected in human colonic epithelial
cells (HCECs) and primary peripheral blood mononuclear cells (PBMCs) incubated with nano-encapsulated
BRD4 inhibitors up to 40 μM. Also, the results of in vivo drug release tests of Nano-BRD4 inhibitors indicate their
good DMPK potential. Furthermore, Nano-encapsulated BRD4 inhibitor PLGA-ZL0513 blocked the colonic
inflammation at a very low dose of 1 mg/kg (p.o.) in a murine IBD model of Dextran sulfate sodium (DSS)-induced
colitis. We hypothesize that local delivery of nanoparticle-encapsulated BRD4 inhibitors targeted to areas of
active colonic inflammation will offer superior pharmacotherapy for IBD with higher efficacy, specific delivery,
long-lasting release, and a safer therapeutic window. In this project, we will pursue the following two Specific
Aims: Inspired by our compelling pilot data, we will compare the in vivo efficacy of nano-encapsulated BRD4
inhibitors with that of their non-encapsulated form on chronic colonic inflammation in murine models that mimic
epithelial injury (DSS-induced colitis) and immunopathogenesis of IBD (both OXA-induced and Cbir1 T cell
transfer chronic colitis) (Aim 1). We will evaluate the in vitro cytotoxicity of nano-encapsulated BRD4 inhibitors
in multiple cell lines and their in vivo acute and chronic toxicity for safety studies in animals. The DMPK profile
improvement (e.g., oral bioavailability and safety) by drug delivery with nanoparticles will also be examined (Aim
2). The proposed studies will lay a solid foundation as the first step in developing a first-in-class orally effective
nano-medication by targeting BRD4 inhibition to improve the treatment of patients with IBD.

Public health relevance
PROJECT NARRATIVE Ulcerative Colitis (UC) and Crohn’s disease (CD), the two major types of inflammatory bowel disease (IBD), are chronic diseases with recurrent symptoms and significant morbidity. This research project is highly relevant to public health as a multidisciplinary investigation of novel nanoparticle-encapsulated BRD4 inhibitors that may be used as efficient nanomedicine therapeutics for IBD and associated diseases (e.g., colitis-associated colorectal cancer), and thus to the NIH mission of developing new medications and fundamental knowledge that will help to lengthen life and reduce the burdens of illness.